Forging a new path with cyclin-dependent kinase inhibitors to treat epithelioid hemangioendothelioma

PROJECT SUMMARY
Epithelioid hemangioendothelioma (EHE) is a rare monogenic cancer caused by a reciprocal chromosomal
translocation that generates the TAZ(WWTR1)–CAMTA1 (TC) fusion gene. No effective treatments exist for
patients with aggressive EHE who do not survive beyond 2 years post-diagnosis. Further, no human cell models
of EHE exist, making both preclinical testing of potential therapeutics and a mechanistic understanding of
aggressive disease quite challenging. To begin to address these problems and identify potential treatments, we
generated two genetically engineered mouse models (GEMM) of EHE: an indolent/less aggressive model, by
recreating TC fusion at the endogenous Taz locus, and an aggressive EHE model by combining TC fusion with
a cyclin-dependent kinase inhibitor 2a (Cdkn2a) conditional knockout. We also derived the first EHE cell lines
from aggressive tumors via ex vivo expansion; however, we were unable to develop cell lines using the
indolent/less aggressive model. TC is a transcriptional coregulator that is predominantly localized to the nucleus;
therefore, we reasoned that drugs/small molecules that translocate TC to the cytoplasm or destabilize TC would
reduce oncogenicity. To this end, we performed phenotypic screening based on TC immunofluorescence to
identify such drugs/small molecules. We identified the cyclin-dependent kinase inhibitor (CDKi) dinaciclib as a
potent drug that can cause TC nuclear exit and destabilization. This translates to decreased cell proliferation and
enhancement of apoptosis, as EHE cells are ‘oncogene-addicted’ to TC. Our long-term goal is to understand
EHE tumor biology and identify a therapeutic vulnerability for the effective treatment of EHE. Aim 1: We will
determine the efficacy of dinaciclib in allograft models of EHE and elucidate its mechanism of action. All the top
hits in our phenotypic screen, including dinaciclib, were transcription inhibitors that prevent the assembly of the
productive transcription elongation complex. Therefore, we hypothesize that incorporating TC into the productive
elongation complex prevents its nuclear exit. To test this hypothesis, we will evaluate by immunoprecipitation
and mass spectrometry whether TC binds to components of this complex and will characterize the TC
interactome after treatment with transcription inhibitors. Aim 2: Evaluate the effect of Cdkn2a introduction on TC
localization and stability in vitro and in allograft models by introducing p16Ink4a and p19Arf, the two major protein
products of Cdkn2a, into our EHE cell line via CRISPR-HDR. Given that CDK inhibition destabilizes TC, we
hypothesize that Cdkn2a, a physiological CDKi, will destabilize TC. Clinically, CDKN2A loss is associated with
late-stage or aggressive disease; however, the underlying molecular mechanisms remain unknown. Therefore,
we will investigate if Cdkn2a decreases TC stability. In sum, this work will be significant because we will have
shown that dinaciclib is potentially the first effective treatment for aggressive EHE, and we will have deciphered
the mechanism linking CDK inhibition and TC nuclear exit/stability.

Public health relevance
Project Narrative Epithelioid hemangioendothelioma (EHE), a rare cancer with no effective treatment, is caused by a protein produced by the fusion of two genes, TAZ (WWTR1) and CAMTA1 that we call TC (abbreviation for TAZ- CAMTA1). Using EHE cancer cells, we screened FDA-approved drugs and identified dinaciclib as a potent TC inhibitor. We propose studies to test the efficacy of dinaciclib in mouse models of EHE and to elucidate its mechanism of action, with the goal of repurposing dinaciclib for the first effective EHE treatment.